Virologic Determinants of Very Early Antiretroviral Treatment Responses of Infants with in utero HIV-1

Project Summary/Abstract
Initiation of very early antiretroviral therapy (ART) in neonates with in utero HIV-1 leads
to the possibility of long-term ART-free control in a small subset of neonates. In the
IMPAACT P1115 clinical trial, very early ART has led to four cases of long-term, ART-
free control in children. In addition to this outcome, sex differences were observed with
respect to plasma viral load, cell-associated HIV-1 DNA concentrations, and the ability
to maintain sustained virologic suppression. These observations are consistent with
previously published research in other cohorts that revealed sex differences in HIV-1
replication capacity and interferon resistance with respect to in utero HIV-1
transmission. To further interrogate the virologic determinants that lead to the formation
of the viral reservoir, we propose to create infectious molecular clones from the gag-pro
and env regions of the near full-length single genome sequences from the proviral HIV-
1 DNA of IMPAACT P1115 participants. These recombinant viruses will be assayed for
replication capacity and interferon resistance, which will be examined against early life
biomarkers of in utero HIV-1 transmission such as plasma viral load, HIV-1 DNA
concentrations, and biological sex. In addition to employing the conventional TZM-bl
and CEM-GXR-25 immortalized cell lines to determine viral infectivity and replication
capacity, we propose to also compare HIV-1 interferon resistance in primary CD4+ cells
isolated from adult males and females or cord blood cells to also investigate the role of
target cell type on interferon resistance. Altogether, these studies will fill a critical gap in
our understanding of retroviral infection in fetal cells and by biological sex and their
implication for sustained virologic control in postnatal life.

Public health relevance
Project Narrative The establishment of a viral reservoir in infants living with in utero HIV-1 is immunologically and virological unique. Determining the replication capacity and interferon susceptibility in neonates with in utero HIV-1 from proviral DNA sequences will aid in developing targeted treatment approaches specific for neonates with considerations for biological sex.